Clinical and neuroimaging determinants of persistent joint pain in psoriatic arthritis

Rebecca Haberman, MD, MSCI is an Assistant Professor (tenure track) in the Division of Rheumatology at NYU
Grossman School of Medicine. Dr. Haberman has a Master’s degree in Clinical Investigation and, despite her
early career stage, has been remarkably prolific with multiple first author publications in high impact journals and
has received competitive extramural funding from NIH/NIAMS (T32 grant), the National Psoriasis Foundation,
and the Rheumatology Research Foundation. Her long-term career goal is to become an independent
investigator who leads both clinical and epidemiologic innovative studies at the intersection of psoriatic disease
and determinants of inflammatory and non-inflammatory pain. Dr. Haberman, together with an expert mentorship
team, guided by Drs. Jose U. Scher and Alexis Ogdie, have designed a career development plan intended to
lead to independence by the end of the K23 award period, including training in outcomes research, advanced
epidemiologic methods, statistical modeling, and clinical trial development as well as developing a fundamental
framework in which to study pain using neuroimaging and validated tools in psoriatic arthritis (PsA). Her work
will be supported by a diverse team of collaborators who have specific areas of expertise in biostatistics,
neuroradiology, pain, and behavioral health and have long committed to helping Dr. Haberman achieve her goal
of independence. Through this award, she will cement her niche within rheumatology and acquire the data and
publications necessary to support a strong R01 application(s). In this proposal, Dr. Haberman seeks to
understand the clinical and physiologic basis of persistent joint pain in patients who have seemingly controlled
inflammation. To do so she proposes to: a) define the prevalence and clinical drivers of persistent joint pain, b)
interrogate the biologic underpinnings of persistent pain using advanced neuroimaging, and c) identify predictive
factors of persistent pain prior to the initiation of PsA treatment. The scientific premise is that while the pain
experience in PsA is mediated by both inflammatory and non-inflammatory processes, persistent pain is largely
non-inflammatory in nature. The central hypothesis posits that, in PsA, a significant proportion of patients
experience persistent joint pain which prevents the achievement of remission unless an effective pain-mitigating
therapy is used as a co-adjuvant. Aim 1 will define the prevalence, phenotype, and drivers of persistent pain in
a large and diverse PsA cohort. Aim 2 will employ neuroimaging (functional brain MRIs) cross-sectionally to
characterize neuroconnectivity differences between patients in full remission and those with persistent joint pain.
Aim 3 will follow newly diagnosed, treatment naïve patients with PsA to assess predictors of having persistent
pain at 6 months after exposure to biologic treatments (including integration of clinical tools with
neuroconnectivity features). The successful completion of the proposed project will provide Dr. Haberman with
a unique perspective and robust tools to study the clinical and neuroimaging features that can serve as the basis
for personalized therapies in PsA, and constitute the foundation of a future competitive R01 grant application.

Public health relevance
PROJECT NARRATIVE Psoriatic arthritis (PsA) is a chronic, immune-mediated disease characterized by widespread skin and musculoskeletal inflammation that affects up to 1% of the population leading to joint swelling, disability and pain. While the use of biologic therapies and other novel treatments has significantly improved the lives of many people with PsA, more than 50% of patients do not respond adequately to these medications and persistent joint pain often remains intractable and a major driver of poor clinical outcomes. Successful completion of our proposed studies will characterize the prevalence and drivers of persistent joint pain, identify changes in brain connectivity that correlate with persistent pain, and develop a predictive model of persistent pain in newly diagnosed, medication naïve patients in order to design adjuvant treatment strategies for pain amelioration and improvement in overall clinical outcomes.